The Neurocognitive Reward Learning Mechanisms of Binge Eating

Binge-eating disorder (BED) is a serious psychiatric disorder, which is associated with a range of negative
outcomes including obesity, psychological impairment, poor quality of life, and premature death. BED is
also the most prevalent and most costly eating disorder, impacting over two million Americans each year.
As treatments for BED are ineffective for over 50% of patients, there is a critical need to clarify the
mechanisms underlying BED maintenance, in order to inform the development of more effective
interventions. Reward learning theories propose that reward prediction error (RPE) – the difference
between the expected and experienced reward from a behavior – plays a key role in behavior
maintenance, and accruing evidence supports this premise in BED. Specifically, research from our group
demonstrates that individuals who experience positive (i.e., better than expected) RPE in response to binge
eating are more likely to maintain their binge-eating symptoms over time. Importantly, multiple distinct
memory systems can underlie this process, and research on other psychiatric disorders has shown that
identifying the precise system contributing to disordered behavior can have crucial treatment implications.
Currently, it is unknown which memory mechanisms contribute to the influence of RPE on binge-eating
behavior. Therefore, this project aims to test how functionally and neuroanatomically distinct memory
systems (episodic, procedural, and working memory) contribute to the relationship between RPE and BED
maintenance. In a BED sample, at baseline, we will capture (1) naturalistic RPE in response to binge eating
using ecological momentary assessment, (2) the neural influence of reward on distinct memory systems
using electroencephalography, and (3) the functional connectivity between reward and distinct memory
systems using resting state functional magnetic resonance imaging. In addition, at a 6-month follow-up
visit, we will assess maintenance of BED symptoms. This will allow examination of how RPE from binge
eating and neurocognitive memory mechanisms might interact to maintain binge-eating behavior.
Knowledge gained from this study will help guide the development of targeted therapeutic approaches
(e.g., neuromodulation, pharmaceutical, psychotherapy) that are designed to directly engage empiricallyidentified
disorder-maintaining mechanisms, which will enhance the efficacy and efficiency of treatments for
BED.